Portable and modular UDS Data Collection software to increase collaboration and engagement of Alzheimer’s Disease Research Center research software engineers

PROJECT SUMMARY
This is an administrative supplement application to the University of Kentucky Alzheimer’s Disease Research
Center (UK-ADRC), submitted in response to NOT-OD-22-068, Administrative Supplements to Support
Enhancement of Software Tools for Open Science. We are requesting funds to support the Data Management
and Statistics (DMS) Core for data management activities relevant to NOT-OD-22-068. The UK-ADRC is an
experienced and collaborative Center whose principal mission is to provide an environment and core resources
that catalyze innovative research, outreach, education and clinical programs. Our overarching theme is
Transitions from Normal to Late-Life Multi-Etiology Dementia. Our well-characterized, longitudinal cohort
and historically strong neuropathology program focused on normal aging, preclinical disease states and early
cognitive transitions have been central to our success in defining early pathogenic mechanisms underlying the
transitions from normal cognitive aging to impairment. In addition, these efforts have been a driving force in our
recognition of the heterogeneity and multiple pathologies that characterize late-life dementia. Our strong and
active DMS Core is critical for integration of the ADRC Cores and is vital to the success of the UK-ADRC. Over
the years, ADRC data collection has grown in scope, scale, and complexity to include not just collection of
UDS data but a multitude of parallel data collections covering clinical, imaging, biospecimens, biomarker, and
biometric data across the ADRC longitudinal cohort as well as other related research studies. The DMS Core
has developed a cloud-based .NET Core MVC web application to collect UDS data in a way that works within
an existing enterprise ecosystem with varied interconnected data sources and stores. We propose here
enhancements to the codebase that include refactoring the codebase for interoperability, adding automated
testing tools for sustainable community engagement, and implementing containerization to facilitate a wide
range of deployment environments.
The specific aims of the supplement are:
AIM 1: Increase software interoperability by refactoring current codebase to decouple the data access layer
from the presentation layer.
AIM 2: Promote ADRC developer community engagement by adding automated testing tools to prepare
codebase for external contributions.
AIM 3: Increase portability and ADRC adoption of software through containerization.
These software tools will be extremely useful not just to the UK-ADRC, but to the national ADRC community by
enhancing the ability to integrate data within a robust large-scale research environment.

Public health relevance
NARRATIVE As our understanding of Alzheimer’s disease and related disorders has grown, so too has the need for powerful, flexible, and shareable research software to support data collection and management in longitudinal studies. The expertise of research software engineers is needed to create these tools, and moreover to create them in such a way that they are readily usable and shareable to other research teams. The tools developed in this project will not only improve operations at the University of Kentucky Alzheimer’s Disease Research Center (ADRC), but also will be a resource to the national ADRC community.